Identifying key engagement characteristics to enhance the effectiveness of digital HIV interventions for at-risk youth

PROJECT SUMMARY
Digital health interventions (DHIs) have shown significant promise in promoting HIV prevention and care
among at-risk youth. Despite the great potential for behavior change that DHIs offer, the effectiveness of DHIs
has varied across studies, largely due to the varying degrees of participant engagement. Therefore,
identifying key engagement characteristics in DHIs is important to evaluate the efficacy of DHIs with rigor
and enhance the efficacy of DHIs for at-risk youth by promoting engagement. DHI studies have utilized
single indicators of engagement, such as amount, frequency, and duration, and have focused on cross-
sectional relationships between engagement and outcomes. This approach has limited the ability to
evaluate the multidimensional aspects of engagement and the prospective effects of engagement on
outcomes over time. Moreover, the one-size-fits-all approach may not be suitable for designing DHIs for
youth. Therefore, there is a need to analyze engagement across multicenter research trials dedicated to HIV
prevention and care for youth in the US. Our research aims to identify key characteristics of engagement to
enhance the efficacy of DHIs for at-risk youth by pooling data from Adolescent Medicine Trials Network for
HIV Interventions (ATN) - UNC/Emory Center for Innovative Technology (iTech) trials. In this study, we
propose using secondary data from more than 900 individuals who participated across five ATN-iTech trials
(MyChoices, LYNX, TechStep, Get Connected, and P3). The study's specific aims are: 1) To harmonize
archived paradata into common data elements of participants' DHI engagement across ATN trials; 2) To
identify engagement typologies and examine their associations with HPC outcomes; and 3) To examine
longitudinal associations between participants’ prospective engagement and desired HPC outcomes over
time. This research significantly contributes to current scientific knowledge by detangle the complex
relationship between engagement and DHI outcomes to optimize DHIs for youth by pooling a multicenter
research network in the U.S. Our findings will help to understand the characteristics driving higher
engagement, rigorously evaluate the efficacy of DHIs while considering engagement, and propose
optimized strategies to promote engagement, ultimately enhancing the efficacy of DHIs for youth. These
insights will provide a blueprint for researchers to rigorously evaluate DHIs and enhance their effect sizes for
adolescents and young adults at risk for HIV and inform the development of an implementation science
framework for engagement in digital HIV interventions, which may be used in future studies for at-risk youth.

Public health relevance
PROJECT NARRATIVE Digital health interventions (DHIs) have shown significant promise in promoting HIV prevention and care among at-risk youth. However, there has been limited effort to understand engagement in DHIs, despite the varying effectiveness of DHIs, largely due to differing levels of participant engagement. This study aims to identify key engagement characteristics in DHIs for at-risk youth, with the goal of proposing optimized strategies to understand the characteristics driving higher engagement, propose optimized strategies to promote engagement, and ultimately improve the efficacy of DHIs.